Outreach and Dissemination

Our Center's Outreach and Dissemination Unit will provide critical links to the external research community, with special emphasis on researchers in physical sciences and cancer biology. Knowledge, inventions and new capabilities created by our research will be made accessible throughout the Center and applications will be actively promoted in the broader research community and the public and private sectors for the benefit of society. Program elements designed to meet these goals will include: Website; Annual symposium; Seminar series; Research project meetings; Visiting scientist program; Training and workshops.

Public health relevance
This PS-OC brings together expert teams from the fields of physics, nano and microfabrication, engineering and cancer biology to develop novel trans-disciplinary approaches to better understand the complexity of cancer metastasis, the aspect of cancer that directly leads to patient morbidity and mortality. Approaches developed by physical scientists will be focused on the study of cancer. Our studies aim to identify novel mechanisms used by cancer cells, but not normal cells, for growth and metastasis to distant body sites. These new mechanism provide novel drug targets, that aim towards arresting cancer metastasis.